Geriatric assessment domains in relation to treatment outcomes among older adults with colorectal cancer

PROJECT ABSTRACT. About 75% of the newly diagnosed colorectal cancer patients are ≥70 years old and
have the lowest 5-year relative survival (61%) due to comorbidity and frailty. Current clinical care guidelines for
older cancer patients only partially address specific challenges experienced by them, thus resulting in large
variations and inconsistency in their standard cancer care. Evidence surrounding complications after colorectal
cancer surgery, treatment toxicity, and their impact on patients’ quality of life (QoL) in older colorectal cancer
patients is inconsistent, and relies heavily on the chronological age of the patient. Thus, there is an urgent
unmet need to evaluate predictors of clinical and patient-reported outcomes in older colorectal cancer patients
in order to aid clinical decision-making and tailor treatment regimens that coincide with patients’ level of risk,
while minimizing complications and toxicities, and improving QoL. The current project is prepared in response
to NIH NOSI NOT-CA-21-031, and will help inform the role of aging-related functional decline on various
clinical and QoL outcomes in cancer patients. The overall objective of this project is to evaluate whether
physical function (Aim 1), a multidimensional brief geriatric assessment tool (Aim 2), and pre-operative
biomarkers of aging (telomere length, mitochondrial DNA copy number), inflammation, nutritional status and a
biological aging score (Aim 3) are associated with postsurgical complications, treatment toxicity, survival, QoL,
and cognitive outcomes in geriatric colorectal cancer patients. Our central hypothesis is that outcomes in
geriatric colorectal cancer patients are associated with physical, functional, emotional, and cognitive status,
irrespective of patients’ chronological age. We propose to recruit a prospective cohort of newly diagnosed
stage I-III colorectal cancer patients (n~462) ≥70 years of age recruited ~2 weeks prior to their cancer surgery.
At study enrollment, we will assess patients’ physical function through Short Physical Performance Battery and
Handgrip testing, and administer a brief geriatric assessment tool developed by Hurria et. al. Biomarkers of
biological aging, inflammation, and nutritional status will be measured in stored blood collected prior to surgery
using well-validated assays. Associations of these exposures with surgical complications (at 30 days),
treatment toxicity, QoL and cognitive function (at 12 months), and clinical outcomes such as survival (at 24
months) will be measured. Our proposed study design is cost-effective as it builds upon a well-established
unique cohort currently recruiting colorectal cancer patients <70 years of age, the ColoCare Study. The
healthcare of older cancer patients extends beyond the traditional management of cancer, and requires
addressing the multifactorial health concerns of this expanding population, making it a significant public health
priority. Information gained in this project may ultimately inform precision geriatric oncology approaches to
improve clinical and patient-reported outcomes in patients at a higher risk of chemotoxicity and death, and to
tailor risk stratification for cancer surveillance in this growing population of geriatric colorectal cancer survivors.

Public health relevance
PROJECT NARRATIVE Predictors of postoperative complications, treatment toxicities, and clinical or patient-reported outcomes in older colorectal cancer patients are not yet completely understood; current clinical management of these patients is largely driven by chronological age, though functional status may be a better predictor of outcomes. We will evaluate clinical and patient-reported outcomes in a prospectively enrolled cohort of newly diagnosed stage I-III colorectal cancer patients ages 70 years and older in relation to physical function, multidimensional geriatric assessment, and relevant biomarkers. Information gained from this project will inform tailored treatments for older colorectal cancer patients based on their physical function, frailty, and biological age, independent of their chronological age.